Retinal neurovascular protection by boosting efferocytosis

Project summary/abstract:
Our research focuses on identifying cellular mechanisms and therapeutic targets for retinopathies caused
by ischemia or trauma including diabetic retinopathy, retinal artery or vein occlusion and traumatic optic
neuropathy. A shared pathogenic event of these diseases is the myeloid cell response to retinal injury. In this
project, we will study ‘efferocytosis’, which refers to the process by which myeloid cells (macrophages/microglia)
clear dead cells by ‘eating’ them. In pathological conditions including stroke, atherosclerosis, and cancer,
efferocytosis is thought to promote resolution of inflammation by clearance of dying cells; however, its role in
retinopathy is poorly understood. We hypothesize that impaired timely clearance of dead cells in the injured
retina contributes to progressive neurovascular damage. Our preliminary data show strong upregulation of the
enzyme histone deacetylase 3 (HDAC3) in retinal myeloid cells after injury. Deleting HDAC3 from macrophages
boosts their efferocytic capacity. Unbiased RNA-seq screening showed upregulation of the pro-efferocytic
secreted protein, CD5 Molecule Like (CD5L) in stimulated macrophages that lack HDAC3. We also observed
that the ‘don’t eat me’ signal cluster of differentiation 47 (CD47), which impairs efferocytosis of dead cells, is
upregulated in the injured retina and this was ameliorated with myeloid HDAC3 deletion. CD47 impairs
efferocytosis by binding to signal regulatory protein α (SIRPα) on myeloid cells. We plan to induce retinal injury
by ischemia or trauma, and then evaluate the impact on retinal outcome of two potential therapeutic strategies
that enhance efferocytosis: deleting HDAC3 in myeloid cells, and neutralizing CD47 or its ligand SIRPα with
antibodies. Our central hypothesis is that: Upregulation of HDAC3 in myeloid cells after retinal injury increases
expression of the “don’t eat me” signal CD47 on apoptotic cells and concurrently downregulates the pro-
efferocytotic molecule CD5L, contributing to defective efferocytosis and worsened retinal outcomes. This
hypothesis will be tested by three related yet independent specific aims: Aim 1 will determine whether myeloid
HDAC3 signals through tumor necrosis factor α (TNF-α) to upregulate CD47 on apoptotic cells and inhibit
efferocytosis in the injured retina. Aim 2 will determine whether myeloid HDAC3 deletion enhances efferocytosis
and retinal injury resolution by upregulating CD5L. Aim 3 will assess whether enhancing efferocytosis by
disrupting the ‘don’t eat me’ CD47-SIRPα axis promotes resolution of retinal injury. We will employ novel
methods to test our hypothesis including high-resolution microscopy, flow cytometry, monitoring of diverse in
vivo retinal neurovascular endpoints, imaging using optical coherence tomography, and assessment of retina
function by electroretinography. Our proposal is designed to provide new insights leading to the development of
new treatments for ischemic and traumatic retinal injury and it aligns with the NEI mission to support research
studying visual disorders and their mechanisms.

Public health relevance
Project Narrative Myeloid cells (microglia and macrophages) can contribute to both tissue injury and repair in retinal diseases. Efferocytosis, a reparative aspect of myeloid cells by which they “eat” and thereby clean up dead cells, is well- studied in some disease conditions, but whether efferocytosis alleviates retinopathy and how this occurs is poorly understood. This proposal is designed to identify new mechanisms involved in efferocytosis with a potential to develop new therapeutic strategies for retinopathies associated with ischemia and trauma.